Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core will provide overall guidance, administrative support, project integration, and fiscal management for the UNC TCORS. Dr. Kurt M. Ribisl will be the Leader of the Administrative Core. Dr. Ribisl is an accomplished researcher and leader who has 28 years of experience in tobacco regulatory science, including success in serving as Principal Investigator (PI) or Multi-PI on three large center grants. The Administrative Core will ensure integration among our efforts by providing the infrastructure and management necessary for coordinating the day-to-day operation of our Center, which includes four Research Projects and two Cores. The Administrative Core will ensure that our Projects and Cores maximize collaboration, support synergy among Projects, help administer career enhancement activities and pilot projects, coordinate with our External Advisory Board, and stimulate effective research dissemination activities.

The Specific Aims of the Administrative Core are to: 1) Foster communication and collaboration across our TCORS Projects and Cores, other funded TCORS, CASEL, and FDA and NIH staff, 2) Ensure that our Center Research Projects address novel and effective strategies to reduce tobacco use among populations who use tobacco products at higher rates than the general population, and 3) Translate and disseminate research to support tobacco control and communication science.

The Administrative Core will provide the infrastructure and management necessary to coordinate the operations of our Center to accomplish our study Aims and achieve our vision of identifying effective tobacco control and communication strategies to reduce and eliminate tobacco use. UNC TCORS investigators have substantial expertise and proven track records in conducting collaborative, interdisciplinary tobacco regulatory science and in disseminating the study findings to broad constituencies.